Structure based design of trimer interface epitope focused universal influenza vaccines

The “Computational Models of Immunity” projects in this application focus on development and
implementation of new structure-based design tools for influenza hemagglutinin (HA) protein
trimer interface specific antibodies or vaccine antigens. These projects will use knowledge about
the structure and function of human neutralizing antibodies to the trimer interface of the HA head
that we have in hand or will discover, in order to design new antibodies or vaccines in silico. We
have access to peripheral blood cells from a diverse panels of subjects with prior natural infection,
or exposure to experimental inoculation with vaccines encoding HA molecules with both seasonal
vaccines and unusual experimental influenza subtypes, including H3variant, H5, H6, H7, H9, and
H10 viruses. The immune B memory cell populations from these individuals are the ideal starting
materials to isolate unusual heterosubtypic antibodies. Recently, we identified the HA head trimer
interface as a major new site of vulnerability for universal influenza antibodies and candidate
vaccines. Here, we will study existing and isolate additional broadly heterosubtypic human
antibodies to the trimer interface of the HA head. We will determine the immunome of the
responding heterosubtypic clones using high-throughput next generation sequencing of antibody
gene repertoires that comprise the clonal lineages of the most heterosubtypic antibodies isolated.
Once antibodies with unusual breadth or activity are isolated, the structure of these antibodies
will be determined in complex with purified HA molecules in the Structural Core using
crystallography and single particle electron microscopy (EM) studies. Such structures will provide
the coordinates for the modeling experiments using Rosetta. We will in silico mature human
antibodies to increase affinity for the HA antigen of specific virus types and use multi-state
design to maximize breadth, i.e., create antibodies that recognize HAs of all clades,
subtypes, groups, or even types. We then will synthesize and express these novel antibodies
and determine neutralization activity, binding affinity, and competition binding groups of designed
antibodies, using a diverse HA panel and pseudotyped viruses with all type A HAs in nature. The
co-crystal structure of these human antibodies with HA will be the template for in silico design of
structurally stable epitope-focused immunogens. We will first validate these designed
immunogens by testing the interaction with the target human antibodies. Further, these
immunogens will be experimentally tested by evaluating immune responses. Then, we will use
the novel immunogens to isolate new antibodies from subjects naturally exposed to influenza, to
show that the immunogens present antigens recognized by natural immune responses.

Public health relevance
The next generation of viral vaccines and biologics alike will be designed rationally, based on a structural understanding of how protective antibodies engage the epitope of the target. The multidisciplinary group in this application will develop and implement new structure based computational models, and then validate the power of the computational design approach with laboratory experiments focused on the structural basis of broad neutralization of influenza through recognition of the a novel site of vulnerability in the interface of the hemagglutinin head domain.